Plasticity in an embryonic gene regulatory network

SUMMARY
The major objective of the proposed research is to illuminate the molecular basis underlying genetic and
epigenetic variation in a major developmental gene regulatory network (GRN). Studies from this and other labs
have identified a cascade of “core” zygotically expressed GATA-type transcription factors, and maternal
regulatory inputs, that activate the GRN controlling development of the endoderm in C. elegans. The latter
include the maternally supplied SKN-1/Nrf2 transcription factor and a triply redundant Wnt, MAPK, and src
signaling system that acts through the LIT-1/NLK kinase and the POP-1/Tcf/Lef transcription factor to initiate
endoderm development. Removal of any one of these inputs results in an impenetrant phenotype, reflecting a
bistable state that shows wide variation between genetically distinct isotypes. Analysis of reciprocal crosses
between isotypes with quantitatively different requirements for SKN-1 in this process revealed that endoderm
GRN output is also influenced by long-term heritable epigenetic states that differ between natural C. elegans
isotypes. This transgenerational epigenetic inheritance (TEI) requires genes involved in piRNA function, the
nuclear RNAi pathway, and histone H3K9 methylation. These findings provide a springboard for unveiling the
molecular basis for genetic and epigenetic plasticity in the regulation of the endoderm GRN. In Aim 1, we will
evaluate hypotheses regarding the mechanisms of action of three genes that differentially alter the requirements
for SKN-1 and Wnt signaling. We will assess how expression of the core regulators of endoderm development
is influenced by quantitative variation in the requirement for the maternal GRN inputs. We will assess how
variation in the requirement for LIT-1 kinase is accommodated in the mechanism that controls asymmetric cell
division leading to activation of the endoderm GRN and will test the hypothesis that quantitative variation in the
requirement for LIT-1 extends to its global action in many asymmetric cell divisions. In Aim 2, we will develop
and implement high-resolution, high-throughput approaches to identifying causal genes underlying variation in
the requirement for the major endoderm regulatory inputs. We will test candidate genes for modulation of the
SKN-1-dependent activation of the endoderm GRN. In Aim 3, we will analyze the molecular basis for
transgenerational inheritance (TEI) of GRN output. We will assess the stages in the endoderm GRN that are
modulated by this TEI and test the hypothesis that epigenetic differences in SKN-1 requirement between
selected isotypes extends to other regulatory inputs. We will test the hypothesis that TEI results from differences
in chromatin states of endoderm genes and that differential expression of non-coding RNAs and endoderm
regulatory genes is associated with TEI. Findings from this research will help to illuminate mechanisms of birth
defects and can provide a paradigm for understanding relationships between an individual’s genotype and
responsiveness to pharmacological agents, of importance to advancing precision medicine. They will also reveal
factors that alter the outcome of Wnt signaling, a major regulatory mechanism associated with many cancers.

Public health relevance
NARRATIVE The conversion of a fertilized egg into a fully developed human comprised of many different cell is orchestrated by genes acting through complex networks. Despite genetic variations between different individuals, these networks generally lead to a faithfully formed human. We propose to reveal how such gene networks operate faithfully in individuals with varying genetic makeups and how non-genetic heritable (epigenetic) effects influence successful outcomes from these developmental gene networks. The findings from this research may lead to a better understanding of the events that lead to accurate embryo development and how genetic and epigenetic alterations can disrupt them, resulting in birth defects. They will also help to illuminate the relationship between an individual's genetics, their propensity for medical difficulties, and their responsiveness to drugs, thereby contributing to advances in precision medicine.